Eastern Europe and Central Asia (EECA) INTERACT conference

Although most countries across Eastern Europe and Central Asia (EECA) are focused on scaling up access to
antiretroviral treatment for the prevention and treatment of HIV, the WHO has warned that the sharp rise in HIV
and tuberculosis coinfections across the region represents a critical threat to both pandemic responses.
Advancing the response necessitates clinical, epidemiological, social, and implementation research to inform
epidemic responses tailored to local contexts. There are specific opportunities to improve the HIV response
across EECA including 1) training local physicians and scientists in the diagnosis, treatment, and management
of individuals with HIV 2) conducting implementation science to optimize program investments 3) ensuring
evidence-informed public health policy and programming to reduce HIV and TB-related disparities across EECA.
The first EECA INTERACT Workshop was held in Kazakhstan in 2019, inspired by the success of the INTEREST
conferences, held annually in different African countries each year, that have benefitted from NIH support for
several years. EECA INTERACT 2019 brought together clinicians, policy makers, early career and senior
researchers, and members of civil society from the region, along with scientists from Western Europe and North
America, to share pivotal findings and experiences in the field of HIV, tuberculosis, and hepatitis C. INTERACT
was innovative and informal, setting the stage for people to participate throughout the two days, focusing on
unique issues facing the region and finding paths forward to solutions for improvement.
The EECA INTERACT 2022 workshop will be a high-quality, regionally-focused scientific international meeting
in Minsk, providing the region’s scientific communities with: 1) platforms to discuss and identify common
solutions to implementation challenges across the region in HIV diagnosis, treatment, and prevention, as well
as tuberculosis, hepatitis, and health more generally; 2) opportunities for early-career clinicians and
researchers to share their experiences and findings from local settings; and 3) mechanisms for prominent
international experts in HIV, related conditions, and social behavioral science to share knowledge and views.
EECA Interact 2022 is being proposed with the following specific aims:
1. To provide cutting-edge knowledge in the fields of HIV, tuberculosis, and hepatitis diagnosis and
treatment, pathogenesis, and prevention, in order to contribute to achieving the 95-95-95 HIV viral
suppression goal, reducing tuberculosis incidence, and lessening the impact of hepatitis across EECA
2. To exchange ideas on providing and supporting HIV testing services and clinical care provision to adults,
adolescents, and key populations living with HIV to achieve the 95-95-95 goals
3. To foster new research interactions among leading investigators and those who represent the potential
future scientific leadership for health care and research in the Eastern Europe and Central Asia region.
4. To build research and clinical capacity across EECA.

Public health relevance
Narrative The Eastern Europe and Central Asia (EECA) region is one of the few regions of the world where new HIV infections continue to grow, highlighting the need for dramatic improvements in the HIV response. Central to effective HIV responses are well-equipped clinicians diagnosing and treating people living with HIV and associated conditions, along with trained researchers studying the most cost-effective interventions tailored to the region’s unique local context. The EECA INTERACT 2022 Workshop in Belarus will: 1) facilitate discussions to identify common solutions to implementation challenges across the region in HIV diagnosis, treatment, and prevention, as well as in tuberculosis, hepatitis, and health more generally; 2) provide opportunities for early-career researchers to share their experiences and findings from local settings; and 3) support prominent international experts in the field of HIV, related conditions, and social behavioral science to share their knowledge and views.